Investigating the functional capacity of autoantibodies in primary membranous nephropathy

PROJECT SUMMARY / ABSTRACT
Membranous nephropathy (MN) is an autoimmune kidney disease in which antibodies against intrinsic
glomerular proteins expressed by the podocyte lead to sublethal podocyte cell injury, loss of the filtration barrier,
and ultimately the nephrotic syndrome. The overall disease course can be quite protracted and the duration and
extent of proteinuria are risks for progressive decline of kidney function and end-stage kidney disease. PLA2R
is the major target in 80% of primary MN cases and the monitoring of circulating anti-PLA2R antibodies (PLA2R-
ab) has been instrumental in following immunologic disease activity and allowing for more rapid treatment
decisions. Yet despite the existence of guidelines for such use of PLA2R-ab serology, nephrologists continue to
have substantial ambiguity about whom to treat with immunosuppression, and when, due to significant variability
in outcome. Patients may develop severe nephrotic syndrome with relatively low titers of PLA2R-ab or relatively
mild disease with very high levels, an observation which remains unexplained. The goal of this proposal is to
identify novel predictors of disease outcome associated with the variable repertoire of PLA2R-ab (which differ in
subclass and epitope specificity) and to better understand the functional consequences of PLA2R-ab-mediated
injury. Aim 1 describes the development of two novel assays that may add to total PLA2R-ab titer in determining
likelihood of clinical remission. One assay will be a simple ELISA to assess the absence or presence of epitope
spreading beyond the N-terminal immunodominant epitope of PLA2R. The second will be a measure of C3c
generation (complement activation) by PLA2R-ab to summate the functional effects of all the IgG subclasses
and epitope specificities. Cox proportional hazards models (survival analysis) will be used to test the associations
between PLA2R-ab levels, C3c generation and epitope spreading with time to the primary outcome (achievement
of partial or complete remission), using two well-characterized MN cohorts. Aim 2 will use IgG eluted from
remnant kidney biopsies from patients with MN to ask whether or not the repertoire of PLA2R-ab that is bound
within the immune deposits mirrors the circulating forms. The manner by which PLA2R is attached within the
glomerular basement membrane (GBM) will also be assessed. Understanding the pathogenic PLA2R-ab that
accumulate with antigen in the kidney deposits, as well as knowing how PLA2R is incorporated into deposits
may offer new insights into disease pathways that could be targeted therapeutically. It has been suggested from
animal studies that the extracellular matrix produced in reaction to the immune injury in MN contains ectopic
elements not usually present in healthy GBM; these have not been extensively studied in human disease. In Aim
3, PLA2R-expressing human podocytes will serve as an in vitro model of PLA2R-ab-induced cell injury to assess
early events that lead to antibody-mediated release of PLA2R from the cell, its binding to conventional and more
novel matrix elements, and to broadly look at changes in extracellular matrix production. The new knowledge
gained from these studies will expand our knowledge of how deposits form and persist in human MN.

Public health relevance
PROJECT NARRATIVE This project seeks to study the ways in which certain antibodies cause the kidney disease known as membranous nephropathy. The information gained from this work has potential to determine if new types of therapy can be useful for the treatment of this disease. As a major part of this project, we will develop a new type of blood test that can provide patients and their kidney care providers with more information about how harmful these antibodies might be to the kidneys, which in turn could determine if treatment is needed immediately or if the disease is likely to dissipate on its own.